Feasibility of a direct brain-to-muscle upper-limb neuroprosthesis

DESCRIPTION (provided by applicant): Implanted neuromuscular stimulation systems capable of restoring full arm and hand motion have now been implemented in people paralyzed below the neck due to spinal cord injury. Intracortical microelectrode arrays are also now being tested in other paralyzed individuals for chronically recording neural activity in the motor cortex. By combining these two technologies, we can potentially develop complete systems that will bypass damage in the spinal cord and restore natural movement by thought to people with spinal cord injuries. However, if the brain signals are decoded into kinematic aspects of movements (e.g. limb position, velocity, joint angles etc.), then we still have to develop additional technology to convert those kinematic commands into the muscle stimulation patterns needed to generate the desired movement. This is not a trivial task. In this study, we will evaluate the alternative approach of retraining the bain to control the muscle stimulators directly, therefore bypassing the challenging and still open problem of how best to translate one's intended movement into the muscle activation levels that will generate those movements. Several studies have shown that local field potentials and the firing rates of motor cortical neurons correlate with recorded muscle activity in able- bodied animals. However, in this study we are specifically testing if motor cortex can be retrained to command the muscle activation levels needed to generate the desired motion of a paralyzed limb where only a subset of the normal muscles can be stimulated and muscles have atrophied after paralysis. Since intracortical recording electrodes are not always capable of detecting firin of individual neurons as the body encapsulates the electrodes over time, we will also compare the effectiveness of using firing rates of the recorded neurons to control the muscle stimulators versus using the more robustly recorded local field potentials to control muscle stimulators. The novel decoding methods we will use in this study can be applied clinically to paralyzed individuals and not just able-bodied animals. In aims 1-2, monkeys will be trained to use the firing rates of ensembles of motor and premotor cortical neurons to control the activation levels of subsets of muscles in a real-time musculoskeletal simulation of a paralyzed arm. The monkeys will be given juice rewards when they successfully move the simulated arm to different targets. In aim1 the monkeys will control movements of the model arm in the horizontal plane by controlling the activation levels of six muscles. In aim 2 external forces will be applied to the model arm. The animals will have to alter the muscle activation levels (by alternating their neural firing) in order to still get the arm to the targets. Aim 3 will determine if the same level of arm control seen in aims 1 & 2 can also be achieved using only local field potentials recorded from intracortical microelectrode arrays.

Public health relevance
PUBLIC HEALTH RELEVANCE: About 17% of the individuals with spinal cord injury are veterans. Injuries high up on the spinal cord can leave an individual paralyzed from the neck down severely limiting their ability to perform activities of daily living. Implanted neuromuscular stimulation technology is now available to activate paralyzed muscles after spinal cord injury and restore arm function. However, these systems need some way to tell the stimulators what the person wants his or her arm to do. This study will determine if we can restore natural arm movement by thought after spinal cord injury by using neural activity recorded in the brain to directly activate muscle stimulators in the arm thus bypassing the damage in the spinal cord. Developing technology to increase independence and function in the most severely paralyzed veterans could significantly improve their physical, financial, and emotional well being.